Discovery and Applied Research for Technological Innovations to ImproveHuman Health

Project Summary
The goal of this project is to translate RF encoding methods developed in an R21 project to human imaging, by
implementing them on a very low ﬁeld human MRI scanner. Its successful completion will enable silent, low-cost
and more portable MRI systems, leading to a substantial reduction in the cost of imaging and improved patient
compliance and comfort.
In conventional MRI, a received signal is localized to its spatial location of origin based on its temporal
frequency, which is controlled using magnetic ﬁelds that are parallel to the main (B0) ﬁeld of the scanner and
vary linearly across space. There are many problems with these B0 gradient ﬁelds: they are loud and induce
peripheral nerve stimulation, compromising patient comfort; they have relatively long switching times due to the
high inductance of the coils; they require bulky cooling systems and customized ampliﬁers; and they are expen-
sive, representing 25-30% of the cost of a clinical scanner. B0 gradient encoding also suffers from spatial errors
due to concomitant terms, which increase with decreasing B0 ﬁeld strength and will limit the performance of
emerging portable and low-cost MRI systems. A potential solution to these problems is to replace B0 gradients
with RF gradients, which are silent and low-cost. Unfortunately, in spite of its potential RF gradient encoding
has not yet become a clinical or commercial success. This is largely due to the fact that no existing RF gradient
encoding method offers the orthogonality between contrast development and spatial encoding that is enjoyed by
B0 gradients, or a straightforward path to convert existing B0 gradient-based MRI scans to use RF encoding. The
methods developed in this project are the ﬁrst to meet these requirements, and will thus be the ﬁrst truly viable
RF gradient-based imaging methods.
The central innovation of this project is to use the Bloch-Siegert (BS) shift to spatially encode the MRI
signal. As with B0 gradients, this encoding mechanism is based on the application of phase shifts to magnetization
directly in the transverse plane, and therefore does not modulate the magnitude of the transverse magnetization,
leaving image contrast unaffected by spatial encoding. The ﬁrst Aim of the project is to develop array and solenoid
RF gradient coils and associated RF hardware to enable 2D and 3D Cartesian brain imaging on a human 0.0475
Tesla MRI scanner, including strategies for simultaneous RF transmission and reception to enable frequency
encoding by BS shift. The second Aim is to develop and implement RF-encoded pulse sequences for brain
imaging based on the BS shift, leveraging key developments from the R21 phase of the project including swept RF
pulses for phase encoding, a theoretical basis and pulse sequence for BS frequency encoding, and RF pulses for
RF gradient-based slice-selective excitation and slice-encoding. The third Aim is to develop image reconstructions
and evaluate the encoding methods in human brain imaging. Successful completion of these Aims will establish
the ﬁrst viable fully RF-encoded human imaging system and pave the way for commercialization and clinical use.

Public health relevance
Project Narrative The hardware currently used for spatial encoding in MRI causes signiﬁcant patient discomfort due to noise and peripheral nerve stimulation, and represents a large portion of the cost of a scanner. This project aims to address these problems through the translation of new spatial encoding strategies using radiofrequency ﬁelds to human MR imaging. The successful completion of this project has the potential to bring about a new generation of silent, more compact and lower-cost clinical MRI scanners.